IMMUNE FUNCTIONS IN OCULAR DISEASES OF OBSCURE ETIOLOGY

In vitro cellular immune functions and lymphocyte subsets are being studied in a masked method in patients with ocular toxoplasmosis, pars planitis, Behcet's disease, geographic choroiditis, and chorioretinitis of unknown origin. Crude ocular antigens, as well as the purified uveitogenic soluble antigen (S-antigen) of the retina, are being used in a lymphocyte microculture technique to evaluate the presence of cellular immune memory to ocular tissues. A subgroup of patients with posterior uveitis has been identified as having this immunologic memory. Lymphocyte subsets in the blood and in the eye are being defined in these patients by monoclonal antibodies. These results shed light on the basic mechanisms of uveitis and may be used as a guide for specific immunologic therapy. In a small group of selected patients, chorioretinal biopsies are performed to evaluate the ongoing ocular immune response.